Oxytocin Mediates Phasic and Tonic Dopamine Release

Project Summary
Substance use disorder (SUD) is prevalent in the US with over 10% of adults fitting the criteria for diagnosis.
Unfortunately, SUD treatments are often unsuccessful, with up to 75% of patients experiencing relapse. SUD is
associated with problematic reward processing, leading to drug use at the expense of natural rewards and
despite negative consequences. Addiction recovery programs often require drug abstinence while reinforcing
engagement with natural rewards such as socialization. Research suggests that oxytocin administration could
help with this process and improve treatment outcomes for SUD. Although the therapeutic potential of oxytocin
is already being investigated in clinical trials with encouraging outcomes, the effects of oxytocin on reward-
related neural circuits are not understood.
The current proposal will assess the region-specific influence of oxytocin receptor activation on neurochemical
release associated with drug and social reward processing. Most studies point to oxytocin decreasing the
reinforcing effects of drugs but increasing the salience of social stimuli. The detection of rewarding stimuli is
regulated in part by the mesolimbic dopamine system, with dopaminergic cell bodies in the ventral tegmental
area (VTA) that project to the nucleus accumbens (NAc). Emerging evidence suggests that different circuits
facilitate drug versus social reward, with drug reward depending on phasic (fast bursts) dopamine release and
social reward on tonic (slow, steady) dopamine release in the NAc. Oxytocin’s therapeutic effects for addiction
may be a result of oxytocin shifting dopamine release patterns from phasic to tonic, thus rebalancing the
pathways facilitating drug and social reward.
The proposed study will be the first to systematically investigate the neural regions in which oxytocin mediates
phasic and tonic mesolimbic dopamine release. Using an established electrochemical technique (fast scan
cyclic voltammetry), we will assess in vivo phasic and tonic dopamine release following microinfusions of a
selective oxytocin receptor agonist into the NAc or VTA. Clarifying the mechanisms by which oxytocin
mediates drug and social reward is crucial for harnessing the full therapeutical potential of oxytocin for SUD.

Public health relevance
Project Narrative Expanding evidence suggests that pharmaceutically targeting the oxytocin system could provide a critical advancement in the treatment of substance use disorder. Oxytocin administration has been shown to decrease the reinforcing effects of drugs while increasing the salience of social stimuli. The proposed study aims to determine the effects of oxytocin receptor activation on reward-related neural circuitry, providing a crucial step for harnessing the full therapeutical potential of oxytocin for substance use disorder.